Core Facility for Aged Rodents

The principal goal of the Core Facility for Aged Rodents (CFAR) is to develop new mouse models that can
be used to evaluate the physiological and cellular factors that control the rate of aging and tie aging to late-life
diseases. New mouse models are often suggested by other scientists, at UM or at other institutions, and these
are evaluated as potential collaborations. CFAR resources are used for initial characterizations, often
including studies of lifespan, age-sensitive indices of health, and pathology, with a view towards producing
sufficient data to allow the new mouse models to be used in competitive applications for extramural support. In
keeping with the overall theme of the UM Pepper Center, many of the mouse systems developed depend on
alterations of metabolic and/or inflammatory pathways, whether by genetic changes, dietary interventions, or,
more recently, drugs. The specific mutants, diets, or drugs chosen each year depend on scientific discoveries
and interactions in each preceding year. Specific Aims: Aim 1 will support eight externally funded projects
(EPs) in year 1, including work on serotonin receptor mutants, drug effects on gene expression patterns, work
on cap-independent translation of specific mRNAs, studies of adipose tissue inflammation, tests of effects of
perinatal oxidant stress, epigenetic markers associated with stress-resistant cells, new inhibitors of PAPPA
enzyme function, and CNS inflammatory changes produced by anti-aging drugs. Aim 2 uses CFAR resources
to maintain breeding colonies of special interest to mouse aging research, including mutants with tissue-
specific alterations in Growth Hormone receptor, the IGF1 binding protein protease PAPPA, a protein that
promotes cap-independent translation of mRNA subsets, and a mouse over-expressing a tumor-suppressor
protein that extends lifespan. Aim 3 focuses on training, consultation, and professional education, so that
CFAR can provide sophisticated perspectives on mouse aging models to PESC and REC applications, and to
UM students, fellows and faculty, and contribute to development of national standards for optimal use of
rodents in biogerontology. Aim 4 involves selection of one or two new innovative mouse models for
development in each year of the award. CFAR has, since its inception in 1989, provided both local and
national leadership in the development of new mouse models for research on the control of aging and its links
to late-life diseases, and hopes to maintain this role in the next award period.